Circadian Mechanisms Governing Cardiac Growth

The incidences of co-morbidities, such as obesity and diabetes, continue to rise, undoubtedly contributing to
increased cardiovascular disease. This includes rising cases of heart failure (particularly HFpEF), for
which in-depth understanding of the mechanisms involved in disease etiology, as well as treatment
strategies, remain unmet needs. With respect to the current application, cardiac processes fluctuate
dramatically over the course of the day, at molecular, cellular, and organ levels; these rhythms are mediated in
large part by the cardiomyocyte circadian clock. We have recently unveiled the beginning of the sleep phase
as a period of accelerated cellular constituent turnover, which is critical for cardiac growth and repair.
Significance of this phenomenon is underscored by realization that cardiac growth only occurs when the heart
is acutely challenged with prohypertrophic stimuli/stresses at the beginning of the sleep period. Moreover,
repetitive challenge of the heart with a prohypertrophic stimulus at the beginning of the sleep period
accelerates adverse cardiac remodeling and contractile dysfunction in models of heart disease. These studies
highlight the importance of temporally coordinating extra-cardiac (e.g., behaviors) and intra-cardiac
(e.g., circadian clocks) influences for the maintenance of normal cardiac function. The precise
mechanisms promoting cardiac growth at the beginning of the sleep period remain unknown. Here, we provide
evidence in support of two distinct contributing mechanisms. Our studies suggest that the cardiomyocyte
circadian clock augments branched chain amino acid (BCAA) catabolism in the middle of the active period,
when cardiac protein synthesis is lowest. This has led us to hypothesize that increased BCAA catabolism limits
BCAA-mediated activation of mTOR and cardiac protein synthesis during the active period (Aim 1). We also
provide evidence that the cardiomyocyte circadian clock activates the integrated stress response (ISR; an
established translation inhibitor) in the middle of the active period. These data have led us to hypothesize that
ISR activation during the active period attenuates cardiac protein synthesis at this time (Aim 2). Surprisingly,
24hr rhythms in cardiac growth appear to be antiphase during HFpEF, peaking during the active period,
leading to the hypothesis that aberrant 24hr rhythms in growth mechanisms contribute to adverse cardiac
remodeling and HFpEF development during cardiometabolic diseases (Aim 3). Collectively, these novel
observations have led to the overarching hypothesis that temporal governance of pathways
orchestrating cardiac growth (BCAA signaling and ISR) are impaired during cardiometabolic disease,
leading to adverse remodeling of the myocardium, such that reinstatement of normal rhythms will
attenuate HFpEF development. Successful completion of the proposed studies will reveal the mechanisms
temporally governing cardiac growth, the extent to which these rhythms are impacted by cardiometabolic
disease, and the efficacy of chronopharmacologic strategies for the treatment of HFpEF.

Public health relevance
Recent studies from our group have revealed circadian clock-mediated oscillations in myocardial processes that are essential for maintenance of normal cardiac function. Here, we will test the hypothesis that disruption of the mechanisms that govern daily oscillations in cardiac growth contribute to the pathogenesis of heart dysfunction during cardiometabolic disease states (e.g., obesity and hypertension). Successful completion of the proposed studies will lead to new fundamental insights regarding the causal role of circadian disruption in the etiology of heart disease, and will highlight restoration of normal circadian governance as a salutary approach for reducing the risk of heart failure.